Development and Testing of imHere4U: A Digital Suicide Prevention Intervention for Cyberbullied Adolescents

Suicide is the second leading cause of death among adolescents, and youth who are cyberbullied are twice as likely to exhibit suicidal thoughts and behaviors as those who are not cyberbullied. Cyberbullying (CB) is strongly associated with suicidal ideation, a phenomenon known to fluctuate rapidly, which suggests need to intervene proximally to instances of CB to reduce suicide risk. There is public health need to reduce suicide risk among cyberbullied adolescents, especially those facing higher rates of CB and suicidal thoughts and behavior. Yet, current interventions are limited in their capacity to meet the needs of youth at elevated risk and to intervene in moments of high vulnerability. The purpose of this Mentored Patient-Oriented Career Development Award (K23) is to provide the applicant, a behavioral health scientist and clinical social worker, with the skills necessary to bridge the gap between CB intervention and suicide prevention with stakeholder-informed and empirically driven digital interventions for adolescents. To accomplish this long-term goal, a multidisciplinary training plan will provide the applicant with expertise in: (1) design, conduct, and analysis of online clinical trials; (2) theory, research, and methods of adolescent CB assessment and intervention; and (3) methods of enhancing adolescents’ utilization of digital interventions using human centered design (HCD) and brief motivational interventions. The applicant will receive mentoring in a strong multidisciplinary environment with accomplished experts in the fields of adolescent suicide prevention, CB research, HCD, and online clinical trials. Formal training and coursework will advance training in clinical trial design and conduct (ethics and social media-based recruitment), and analysis (mediation and moderation analysis and evaluation of machine learning [ML] models for clinical trials), CB research, and methods for enhancing engagement (HCD and motivational interviewing). A complementary research plan will focus on development and testing of imHere4U, a just-in-time, suicide prevention intervention for cyberbullied adolescents. Based on pilot data suggesting acceptability of imHere4U among cyberbullied youth, parents, and professionals, we propose three aims. Aim 1: Cyberbullied adolescents (N=20) will participate in iterative design to optimize a digital product for their needs. Aim 2: Recently cyberbullied adolescents (N=80) will participate in an online RCT testing imHere4U plus Questionnaires of online interactions vs. Questionnaires alone. Aim 3: We will examine the feasibility of using a ML algorithm to deliver feedback to adolescents on their supportive and bullying online interactions. This trial will test the feasibility and preliminary efficacy of imHere4U, essential data for a subsequent R01 application to test imHere4U’s efficacy within a larger sample and dissemination outcomes. Results from this investigation are expected to lead to an efficacious intervention that fills a critical gap in service delivery by intervening when and where CB occurs to prevent adolescent suicide risk.

Public health relevance
This project seeks to determine whether a stakeholder-informed intervention delivered via a chatbot can be an effective means to reduce suicide risk among cyberbullied adolescents. By intervening proximally to incidents of cyberbullying when adolescents are vulnerable to suicidal ideation, this research has significant potential for public health impact. Ultimately, this research will inform the feasibility and initial efficacy of a digital just-in-time suicide prevention intervention for cyberbullied adolescents.